Cancer Research Career Enhancement and Related Activities

CANCER RESEARCH CAREER ENHANCEMENT & RELATED ACTIVITIES (CRCE)
ABSTRACT
The UCLA Jonsson Comprehensive Cancer Center (JCCC) remains committed to exceptional cancer research
education, mentorship, and training to supports trainee career development and provide a foundation for ongoing
progress against cancer. The mission of the JCCC Office of Cancer Training and Education is to foster innovation
and excellence in interdisciplinary cancer education and training through partnerships and to create innovative
and complementary cancer-related education and training programs for all trainee levels. The Office leads in
coordinating and organizing activities for rich and diverse cancer education and training programs already
existing in campus departments/centers/institutes and at key UCLA partner institutions. The Office is creating
new training and educational activities and expanding these efforts in the next project period. Ongoing Office
activities include: (1) A Cancer Education Steering Committee to guide priorities on resource allocation and
opportunities to enhance cancer training and education activities broadly. (2) A deeper commitment and focus
on mentored assistance in NIH F-type award application development supported by a new JCCC fellowship
program. (3) A Women in Oncology Initiative that stimulates career development for women within the JCCC
Los Angeles County (LAC) catchment area. (4) Additional resources and emphasis on clinical cancer research
training through the JCCC Clinical Research Unit (CRU) and the Translational Research in Oncology (TRIO-US)
clinical trials Network. (5) Continued support of the Minority Training Program in Cancer Control Research
(MTPCCR), to overcome a void left by the ending of the NIH program that supported this activity since 1998.
The practical objective of the JCCC Office of Cancer Training and Education is to enhance a rich learning
environment, provide additional resources, and identify career development opportunities within UCLA, key
partner institutions, and throughout our surrounding LAC community. Supported programs span the spectrum of
trainee levels. The Office provides administrative and informational oversight of cancer research educational
offerings and related activities. It serves as a coordination center for all cancer related educational activities in
the JCCC, and provides an academic and administrative scaffold for supporting cancer-related training and
education in basic, clinical, and population sciences. To achieve its mission and objective, there are three specific
aims. (1) To identify, integrate, and support existing cancer-relevant education and training activities. (2) To
create and coordinate new cancer education, career development, and mentorship programs and activities. (3)
To engage trainees from underrepresented groups and support their cancer career development.
Maie St. John, MD, PhD (STT) leads the JCCC Office of Cancer Training and Education and is responsible for
implementing the education, training, and mentoring approach prioritized in the recently completed 2019 – 2023
JCCC Strategic Plan.